Population Biology of African Malaria Vectors and Parasites

Project Summary
Malaria remains the most devastating vector-borne disease in Africa. The primary interventions,
insecticide-treated nets and indoor residual spraying, target indoor-biting mosquitoes. However, the
effectiveness of these tools has been significantly hindered by the spread of insecticide resistance and
the increasing tendency of malaria vectors to bite outdoors, slowing malaria control progress across
Africa. Additionally, the recent invasion of Anopheles stephensi, a major malaria vector in South Asian
urban environments, presents a new and significant threat to malaria control efforts in Africa. This
invasion, along with rapid urbanization on the continent, has created additional challenges for malaria
control in Africa. To address these challenges, it is essential to understand the biology of An. stephensi
in its newly-invaded African habitats, its impact on malaria epidemiology, and to develop new vector
control methods suited to urban environments. Advances in molecular biology, genomics,
bioinformatics, and ecological modeling offer exciting opportunities to track and contain the spread of
An. stephensi and develop new control methods in rapidly growing urban areas. Unfortunately, many
scientists from malaria-endemic countries have not fully leveraged these technologies in their research.
In previous funding cycles, our D43 research training program has achieved remarkable success in
training African scientists in vector biology and malaria research. However, significant gaps remain,
particularly in the research capacity for invasive vector species in Ethiopia and other African countries.
Accordingly, the overall training objectives are to advance the career development of promising young
scientists from An. stephensi-infested African countries, strengthen institutional research capacity in
invasive disease vectors and promote sustainability among malaria researchers in Ethiopia. We plan
to achieve this by training ten PhD students, four postdoctoral fellows and 20 junior scientists from
these regions through mentored research in vector biology and malaria epidemiology, and through
workshops and short and intensive training courses on grant writing and scientific leadership
development. In addition to mentored research, the program will offer a core curriculum focusing on
biostatistics, genomics, bioinformatics, modeling, scientific writing, and responsible conduct of
research. The infrastructure and capacity at our international training sites in Ethiopia and at the
University of California, Irvine, are ideal for this training. This program will significantly enhance
institutional research capacity in invasive disease vectors and malaria in Ethiopia and aid the career
development of African scientists by bridging laboratory and field research in vector biology and malaria
epidemiology, enabling researchers with innovative technologies, fostering Africa-wide and
international collaborations, and supporting them to become independent scientists.

Public health relevance
Public Health Relevance: The recent invasion of Anopheles stephensi mosquitoes poses a new and significant threat to malaria control efforts in Africa. Advances in molecular biology, bioinformatics, modeling, and other disciplines provide exciting opportunities to develop new and effective An. stephensi surveillance and control tools. Training next-generation scientists to enable them to effectively use the new technologies and enhancing the malaria research capacity will greatly facilitate malaria control efforts in Africa.